Robust and efficient statistical inference methods for genomics

PROJECT SUMMARY
Technological advances in sequencing and experimental assays have greatly increased the availability of vari-
ous kinds of genomic data, enabling us to catalog genetic and epigenetic variation in diverse populations, and
to probe fundamental biological processes (e.g., transcription and translation) in unprecedented detail. This de-
velopment is providing a number of new opportunities for basic and biomedical research, but often the data are
noisy and multifaceted, while the underlying biology is very complex, thus presenting both theoretical and com-
putational challenges for analysis and interpretation. New efﬁcient and robust statistical inference tools, as well
as theoretical analysis of mathematical models, are much in need of development to bring the promise of the big
data era in biology to full fruition. The central goal of the parent project (R35-GM134922) is to develop a suite
of useful statistical and computational tools that will help to tackle this challenge, by enabling inference under
complex models and helping researchers integrate information from different types of data to reveal fundamental
biological processes. In particular, the parent project aims to achieve the following goals: (1) Improve and widen
deep learning/neural network applications in genomics. (2) Leverage cutting-edge techniques in natural language
processing (NLP) and massive protein databases to improve biological sequence representations, which can fa-
cilitate downstream prediction tasks. (3) Develop novel computational methods for integrative analysis of genomic
data. By utilizing modern Graphics Processing Units (GPUs) provided by this supplement award, we will train and
publicly release improved NLP-inspired neural network models for biological sequences that will be useful to the
genomics community.

Public health relevance
PROJECT NARRATIVE This project will develop a suite of statistical and computational methods for genomics that are robust and efﬁcient. This research will enable inference under complex population genetic models, and help biomedical researchers integrate information from various types of genomic data to reveal fundamental biological processes, thereby broadly facilitating efforts to understand the genetic basis of human biology and disease risk.